2025 Biennial Perceptual Learning Workshop

Project Summary
This application requests funds for travel awards to expand the diversity of attendees at a long-standing
Biennial International Perceptual Learning Workshop.
Robust improvements in visual perception can be induced through experience on a variety of visual tasks.
This visual perceptual learning has the potential to provide powerful insight into the organization and
flexibility of the mammalian visual system. The recognition that visual perceptual learning can be clinically
applied to improve visual functions with age and disease have intensified recent efforts to optimize and
characterize training paradigms and standardize outcome measurements. In addition, the persistence of
perceptual learning in the adult visual system contributes to a revision of our understanding of how the
capacity for plasticity is retained in mature sensory cortices. The overall goal of this international
conference is to provide a forum for discussion and debate of recent advances, long-term debates and
new directions for the field of perceptual learning.
This conference has become an important opportunity for individuals across the globe with expertise in
perceptual learning ranging from psychophysics, neurophysiology, functional imaging, computational
neuroscience, and perceptual rehabilitation to receive critical commentary of new unpublished work, and
to influence and learn from each other. The conference attracts both pioneers and newcomers to the field,
and has a strong representation of NEI-funded American scientists. The meeting serves an important need
as the field of perceptual learning is highly interdisciplinary and there are no other forums that bring
together researchers across the many disciplines that contribute to the field. The meeting also has been
successful in enhancing interactions between junior and senior investigators, providing opportunities for
new collaborations and influencing subsequent work by identifying the most important issues in the field.
The specific goals for the 2025 Visual Perceptual Learning Workshop are:
Specific Aim 1: To highlight new and exciting developments on the frontiers of perceptual learning.
Specific Aim 2: To promote communication and interactions between meeting attendees
Specific Aim 3: To achieve the highest scientific quality and diversity, by optimizing a balance of gender,
age, ethnicity, and nationality.

Public health relevance
Project Narrative This application requests funds for travel awards to expand the diversity of attendees at a long-standing support the Biennial International Perceptual Learning Workshop, to be held in June 2025, which will feature scholars from around the world from diverse and complementary disciplines that represent the breadth of the field of perceptual learning. The workshop will showcase the latest conceptual insights and technical advances in psychophysics, neurophysiology, functional imaging, computational neuroscience, and perceptual rehabilitation. The conference attracts both pioneers and newcomers to the field, and has a strong representation of NEI-funded American scientists.